Probabilistic Multiscale Modeling of the Tumor Microenvironment

Abstract
The research project proposed here addresses the pressing need for better statistical models and methods to
analyze the spatial architecture of the tumor microenvironment (TME). TME data has demonstrated there is clear
clinical and biological importance in the spatial architecture, e.g. as a determinant of response to treatment and
metastasis. Given the recognized importance of the TME in cancer, technology has advanced at pace to profile
the spatial properties of tumors using high resolution measurements including spatial transcriptomics and
proteomics. However, the requisite computational methods to fully interpret these measurements are lagging.
Accordingly, in Aim 1 we will develop a statistical framework, which we call BayesTME to model the TME at
multiple scales, ranging from the level of individual cells to top-level patient stratification. We will develop
BayesTME as a suite of innovative statistical methods for Bayesian multiscale spatial modeling that would enable
a new class of spatial statistical models to quantitatively evaluate the properties of the TME. We have gathered
a diverse and scaled collection of spatial profiling datasets upon which to test, benchmark and evaluate
BayesTME. In developing BayesTME, we will create modular tools in Aim 2 that can use the same statistical
concepts across different technologies such as multiplexed immunofluorescence, imaging mass cytometry and
spatial transcriptomics. This will permit statistical integration of datasets that may have been generated with
diverse sets of technology. In addition, we will include an extension to the base BayesTME to identify recurrent
spatial properties across a cohort of samples, enabling discovery and quantitative description of spatial
communities that related to specific cancer phenotypes. Finally, in Aim 3 we propose a validation experiment
that will generate parallel spatial profiling data–in the form of spatial transcriptomics and imaging mass cytometry
from the same ovarian cancer specimens. This dataset will help to address a critical question in ovarian cancer
which is how TME dynamics enable bowel metastasis - a major determinant of morbidity and mortality for women
with ovarian cancer. In summary, the goals of this proposal are to develop a robust, new class of statistical
methods for analyzing the spatial architecture of the TME, generate robust open-source software enabling
application of our methods across multiple spatial profiling techniques, and validate our methods and software
by using them to conduct large-scale data analyses investigating novel biological hypotheses regarding the
spatial architecture of the TME. Accomplishing these goals will lead to new quantitative encoding of the
properties of the TME that are statistically grounded that will in turn lead to a new class of spatial biomarkers to
define malignant phenotypes in cancer.

Public health relevance
Project narrative Basic patterns in the spatial layout of cells in a tumor can influence patients’ response to therapy and metastasis, and while significant technology development to measure the properties of cells in intact tissues have advanced at pace, detailed and robust investigations have been limited by a lack of computational methods for analyzing spatial tumor data. This proposal addresses this gap by developing and validating new statistical methods and algorithms capable of (i) extracting rich patterns from spatial tumor data, (ii) generalizing across multiple spatial technologies, and (iii) validating on real-world data from ovarian cancer patients. Addressing this gap will lead to new fundamental discoveries in cancer biology and enable the rational design of spatial biomarkers to enable biological discovery and a new generation of single cell spatial properties of tumors.